MORRIS BROWN COLLEGE DRUG ABUSE RESEARCH DEVELOPMENT PROGRAM

The purpose of the Morris Brown College Research Support Program grant application is to seek funds to continue our efforts to achieve the following goals: (1) to encourage faculty in the natural and social sciences, mathematics, nursing , and psychology programs to pursue basic research in the areas of alcohol, drug abuse, and mental health (ADM); (2) to strengthen the research environment that supports research in these areas; and (3) to provide research participation experiences for undergraduate students which will encourage them to pursue post-graduate studies and research in alcohol, drug abuse, or mental health fields. Founded in 1881 by the African Methodist Episcopal (A.M.E.) Church, Morris Brown College is one of seven historically black collages in the Atlanta University Center consortium. It is a private nonprofit coeducational 4-year college with over 2,000 black students majoring in 35 fields of study including ten ADM-related fields. The Research Support Program proposes to continue supporting faculty research development through several activities. A Research Support Advisory Committee will be created to advise the Vice President for Academic Affairs of the needs and concerns of the research faculty at the college. Other support will include providing computerized literature searches, photocopying of research literature, provide close grantsmanship mentoring by senior scientists and experienced writers, support travel to scientific workshops to assist faculty in keeping up with state-of-the-art research techniques, and initiate a Visiting Scientist Program so senior scientists may visit the campus for extended periods of time. The work of the first two years of the previous grant resulted in this application which includes 5 proposals, 4 from faculty who are first-time proposal writers.